NCITU: National Center for In-situ Tomographic Ultramicroscopy. Supplement

Summary
The National Center for In-situ Tomographic Ultramicroscopy (NCITU) is based at the Simons Electron
Microscopy Center (SEMC), which is a part of the New York Structural Biology Center (NYSBC), based in New
York, NY. NCITU is dedicated to developing and providing access to both standard and advanced methods for
in-situ cryoET specimen preparation, and to disseminating this expertise through a cryoET cross-training
program designed to serve a wide variety of skill levels and career goals.
The primary goal of the National Center for In-situ Tomographic Ultramicroscopy (NCITU) is to provide user
access and service towards preparing specimen for direct visualization of macromolecular associations and
organization, particularly in native cells. A highly qualified technical team provides direct hands-on service,
guidance, and assistance to ensure that samples and grids are prepared with the highest quality and in the
shortest time possible. An already well established cross-training program is being expanded and extended to
provide training in every aspect of the cryoET specimen preparation pipeline.
This is a request for supplemental funding for the National Center for In-situ Tomographic Ultramicroscopy
(NCITU) to enhance the Center's data analysis and CLEM capabilities. This is a specific request for (i) a
dedicated cryoET processing workstation, (ii) a Zeiss LSM 900 software upgrade, and (iii) a second Linkam
CMS196 cryo CLEM stage.

Public health relevance
Project Narrative CryoET has unique capabilities for directly visualizing macromolecular associations and organization in native cells. NCITU will provide nationwide access to state-of-the-art equipment, technical support, cross-training, and methods development towards disseminating new services to enable and streamline specimen preparation for cryoET.